Data Center for Acute to Chronic Pain Biosignatures

Project Summary
Understanding the mechanisms underlying the transition to chronic pain is key to
mitigating the dual epidemics of chronic pain and opioid use in the U.S. As part of the NIH
funded Acute to Chronic Pain Signatures (A2CPS) Program, we have established a Data
Integration and Resource Center (DIRC) at Johns Hopkins University and collaborating
institutions that works to integrate imaging, omics, behavioral, and clinical measures to
develop biosignatures for the transition to chronic pain. In this administrative supplement
we seek funding for an additional three-year period to continue data capture, processing,
and analysis.

Public health relevance
Project Narrative: Understanding the mechanisms underlying the transition to chronic pain is a key to mitigating the dual epidemics of chronic pain and opioid use in the U.S. As part of the NIH Common Fund Acute to Chronic Pain Signatures (A2CPS) Program, we will establish a Data Integration and Resource Center (DIRC) entitled the “Data Center for Acute to Chronic Pain Biosignatures” at Johns Hopkins University (JHU) and collaborating institutions. The Center will integrate imaging, peripheral physiology, genomics and other omics, behavior, and clinical measures to develop biosignatures for the transition to chronic pain.